Macrophage Factor XIII-A in Provisional Extracellular Matrix Modification and Epithelial Repair during Acute Lung Injury

PROJECT SUMMARY
Project Summary: This proposal describes a 5-year research training program that will develop Dr. Peter
Moore into an independent basic and translational physician-scientist. His long-term career goal is to advance
the fields of ARDS, extravascular coagulation, and epithelial repair through the elucidation of mechanisms
underlying repair after acute lung injury (ALI). During this K08 Award, Dr. Moore will gain specific career
development training and mentorship closely aligned with an innovative research plan. He proposes to study the
role of macrophage-produced coagulation factor XIII-A in regulation of the extracellular matrix (ECM) and
alveolar epithelial repair after ALI. Given its applicability to multiple pulmonary disorders and repair of injury in
other organs, this work is directly relevant to the NHLBI.
Candidate: Peter Moore MD, is a board-certified Pulmonary and Critical Care Medicine physician-scientist at
the University of Colorado Anschutz Medical Campus. His record of academic excellence, basic science
research and scientific publications demonstrates a firm commitment to a career as a clinician-scientist.
Training: The proposed career development plan augments Dr. Moore's prior mentored research during his
undergraduate, medical, residency, and fellowship training. He proposes to meet his short-term objectives
through an integrated combination of intensive mentoring by internationally renowned experts in macrophage
biology, ECM proteomics, and transglutaminase activity in tissue repair with didactic and hands-on experiences
in (i) extravascular coagulation, (ii) proteomics, (iii) in vivo and ex vivo models of epithelial repair, (iv) scientific
writing and presentation, and (v) laboratory leadership.
Mentor / Environment: Dr. Moore has close working relationships with highly experienced mentors and
collaborators who contribute expertise in macrophage and lung biology (Drs. Janssen, Schwartz, McCubbrey,
Mould, Redente), ECM proteomics (Dr. Hansen), extravascular fibrin and transglutaminase activity during tissue
injury/repair (Dr. Luyendyk), and innovative tissue imaging techniques (Dr. Schwartz, Redente). The proposed
activities will be based at the University of Colorado and National Jewish Health, top-ranked research institutions.
Research Project: The primary objective of this proposal is to identify the mechanism by which monocyte-
derived macrophage (moMΦ) production of factor XIII-A (FXIII-A) enhances repair after ALI. Specifically, our
studies will test the hypothesis that FXIII-A produced by moMΦ at sites of injury crosslinks components to the
extracellular matrix that improves type 2 alveolar epithelial cell replication, migration, and differentiation to type
1 alveolar epithelial cells after ALI. This will be tested with well established murine models of acute lung injury
and human biospecimens using specialized ECM proteomics, atomic force microscopy, and time-lapsed imaging
of precision cut lung slices and decellularized lung scaffolds. In doing so, the specific contributions of moMΦ
FXIII-A's modifications of the ECM to repair after acute injury will be elucidated.

Public health relevance
PROJECT NARRATIVE Targeting processes that enhance alveolar epithelial repair could improve outcomes from acute inflammatory lung diseases like the acute respiratory distress syndrome (ARDS). Using murine models and human biospecimens, we will test whether factor XIII, a coagulation protein, produced by lung macrophages enhances alveolar repair through its influence the structure of the extracellular environment. This proposal aims to uncover key mechanisms underlying lung repair and pave the way for developing novel treatments for ARDS and other inflammatory lung disorders.